New fractional calculus models of attenuation for shear wave elasticity imaging

Abstract Shear wave elasticity imaging with ultrasound is an exciting new diagnostic modality that holds great promise for noninvasively imaging the mechanical properties of soft tissue. Despite the signiﬁcant potential of ultrasound- based shear wave methods for imaging liver ﬁbrosis and other important soft tissue pathologies, some signiﬁcant problems remain unsolved. In particular, present quantitative shear wave parameter estimation approaches neglect some fundamental physics, namely the combined effects of shear wave diffraction and power law attenua- tion. As a result, present shear wave elasticity imaging approaches yield different results with different ultrasound probes when applied to the same viscoelastic shear wave phantom. In addition, numerical validation of shear wave parameter estimation approaches is presently hindered by the available three-dimensional (3D) simulation models for shear waves in soft tissue, which all have some fundamental problems. For example, integer-order partial differential equations fail to accurately represent the attenuation of shear waves in soft tissue, which follows a power law. Although fractional calculus is ideal for modeling power laws, 3D numerical computations that numerically evaluate time-fractional derivatives are computationally prohibitive with ﬁnite difference or ﬁnite element methods, so alternative approaches are needed for 3D numerical simulations of shear waves in soft tissue. We propose to solve these problems through the completion of two speciﬁc aims. In Aim 1, we will validate new 3D fractional calculus simulation models that describe the effects of shear wave diffraction and power law attenuation in soft tissue, where the new models are amenable to 3D numerical computations on computers with a modest amount of memory, unlike existing fractional calculus models. The new fractional calculus models will also describe the power law attenuation for the entire range of parameters observed in soft tissue, in contrast to existing fractional calculus models, which all break down within the central range of observed values. In Aim 2, we will establish new fractional calculus models for shear wave parameter estimation which are based on an approximation to the 3D fractional calculus models that we are proposing for forward shear wave calculations. We propose to show, through evaluations performed with 3D simulated and measured shear wave data, that the proposed fractional calculus estimator yields much more accurate values for the shear elasticity than estimates obtained from present state-of-the-art time-of-ﬂight and k-space approaches. Thus, we propose to overcome several important deﬁciencies of the present models for forward calculations and parameter estimation, where the proposed fractional calculus models are ultimately expected to achieve signiﬁcant improvements in the consistency of noninvasive shear wave parameter measurements that will provide translatable effects in practice for important clinical applications of shear wave elasticity imaging.

Public health relevance
Project Narrative Shear wave elasticity imaging, which generates shear waves with an acoustic radiation force `push,' is an emerg- ing modality with great potential for noninvasively imaging the mechanical properties of soft tissue. However, present state-of-the-art approaches for ultrasound-based shear wave imaging neglect some fundamental physics, which causes problems with the consistency of measured values while producing signiﬁcant errors in the esti- mates for the shear elasticity in soft tissue. We propose to solve these problems with new fractional calculus models that enable 3D shear wave simulations of power law attenuation in soft tissue and that also enable much more accurate estimates of shear wave parameters, thereby eliminating important obstacles that presently limit the effectiveness of shear wave elasticity imaging.